Facilitating a Multi-Institutional Enterprise

Title: Biotechnology Resource Center of BioModular Multi-scale Systems (CBM2) for Precision Medicine
Administration: Facilitating a Multi-Institutional Enterprise
Abstract/Summary
The Biotechnology Research Center of BioModular Multi-scale Systems (CBM2) for Precision Medicine, which
is seeking to continue its important mission through this competitive renewal application, has outlined an
aggressive and highly innovative research program that will generate new technology platforms for the analysis
of markers secured from circulation as part of the Liquid Biopsy initiative. These markers include rare biological
cells, cell free DNA, and extracellular vesicles as well as the molecular cargo they carry (DNAs, RNAs, and
proteins). In its active rendition (2015-2020), CBM2 generated new platforms for the isolation of these liquid
biopsy markers and amplification-based molecular assays of their cargo that can be used to guide clinical
decisions for a number of important disease states (i.e., Precision Medicine). Unique to this competitive renewal
is the evolution of innovative tools to enable the analysis of the liquid biopsy's molecular cargo without requiring
amplification that will provide unique opportunities, such as the analysis of epigenetic modifications in DNAs and
RNAs. Our platform technology is innovative in that the isolation steps will be integrated to the molecular analysis
steps to form fully automated mixed-scale (micro- and nanotechnologies) and modular fluidic systems. The fluidic
systems will be populated with task specific modules produced from the expiring P41 as well as innovative ones
evolving from the TR&Ds in this competitive renewal. All modules are manufactured in plastics using injection
compression molding. The modules can also be used as standalone units to facilitate dissemination.
The lofty goals envisioned by CBM2 will be realized through an accomplished multidisciplinary team of
researchers across several institutions that possess complementary skill sets. The Administrative Core of the
Center will seek to coordinate activities between the Center's researchers to aggressively move the research
program forward in a timely manner to provide compelling outputs that will not only provide unique opportunities
for the Center's Collaborative and Service Projects, but the biomedical community as a whole. The Center's
leadership team is seasoned with extensive experiences in managing large research organizations that have
demonstrated success within the research community as well as generating compelling training programs for a
variety of audiences with an interest in liquid biopsies and mixed-scale fabrication. The Leadership Team will
coordinate the research efforts of the Center with its Collaborative Projects to allow for application driven
development of the proposed technologies. The Center is well versed in transitioning its technologies into the
commercial sector to facilitate dissemination that will increase Center visibility through Service Projects. The
system design approach adopted by the Center (modular format) will facilitate the generation of integrated fluidic
systems for automating complex assays. Collaborative and Service Projects will also evolve from the Center
through the engaging Training and Dissemination Program including a robust website and extensive networks
provided by the Leadership Team as well as an active Visiting Scholar's Program.

Public health relevance
Narrative The Biotechnology Resource Center of BioModular Multi-scale Systems for Precision Medicine is seeking to evolve its mission, which is to design, model, fabricate, test and translate into the biomedical community innovative tools to enable precision medicine across different disease states using liquid biopsy markers. The lofty vision for the Center will be realized through a stable and engaging Administrative Core that will facilitate the timely delivery and dissemination of innovative tools into the research and clinical communities.